Administrative Core

Project Summary – Core A
The essential services provided by the Administrative Core include:Administrative support for all the investigators
in each Project and Core, fiscal management and oversight for all components of the Program Project, and
organization and communication of all SPORE meetings and activities. The overall goal of this Core is efficient
stewardship of the SPORE. The roles of the Administrative Core co-Directors and administrative staff are to
facilitate communication while stimulating scientific and technological interactions. This will be achieved by 1)
Establishing an administrative structure to provide support and management for all Projects, Cores, and Pilot
Project activities, 2) Fostering collaborative research, and 3) Ensuring compliance with regulatory and
governmental guidelines. Overall, The Administrative Core A of this SPORE is designed to provide scientific
leadership, effective communication, and an administrative support structure to ensure the coordination of all
SPORE activities.

Public health relevance
Project Narrative – Core A The overall goal of the Administrative Core is to provide the administrative structure for the efficient and fair review and allocation of resources, scientific and regulatory oversight, and to act as a conduit for the rapid execution of SPORE goals. Core A will facilitate the sharing of resources, the communication between the investigators, and provide oversight for the awarding of career enhancement and pilot awards. This Core includes a clinical trials advisory committee, specifically designed to accelerate the pace of translational research, a key objective of this SPORE proposal.